Development of ALM-488 for nerve and ureter visualization during abdominal surgery

PROJECT SUMMARY
Fundamental to the goals of surgery are functional preservation of critical nerves and minimization of post-
operative patient morbidity. Unfortunately, inadvertent nerve injury during surgery continues to be a major cause
of post-surgical patient morbidity due to the inability of surgeons to visualize nerves during surgery. Nerve injury
is a frequent postoperative complication of minimally invasive surgeries, leading to significant patient morbidity
and long-term consequences that can include chronic pain, numbness, urinary and defecatory dysfunction,
sexual dysfunction, and paralysis. Inadvertent intraoperative ureteral injuries additionally contribute to the high
rate of postoperative complications in this patient population. Current nerve identification strategies utilize non-
quantifiable criteria such as anatomy, texture, color, and relationship to surrounding structures to distinguish
nerve or ureter from non-nerve tissues. In instances of trauma, tumor invasion, or infection, nerve identification
using the above criteria is especially challenging and often fails to prevent nerve damage. Using white light
reflectance, which is the standard mode of illumination in operating rooms, the visual difference between small
nerves and adjacent tissue can be imperceptible. There is an unmet need to improve the intraoperative
visualization of nerves and ureters to preserve their function and minimize patient morbidity following surgery.
There are currently no clinically approved agents that enhance nerve and ureter contrast in the same surgery.
Alume Biosciences has developed a first-in-class IV-administered agent for nerve visualization. This candidate,
ALM-488, is a peptide dye conjugate that binds motor, sensory, and autonomic nerves in vivo and enables nerve
visualization with high nerve to non-nerve contrast with no inherent toxicity. ALM-488 fluoresces at a wavelength
that is compatible for potential dual use with Near-infrared (NIR) tumor agents, and thus, is well suited to deliver
on the complimentary goals of enhancing tumor tissue and nerve visualization during resections. In preclinical
studies, ALM-488 labels both nerve and ureter with high selectivity, both of which can be easily visualized using
existing clinically approved endoscopes. Critically, ALM-488 has recently completed clinical testing for nerve
delineation in open head and neck surgeries, which demonstrated that ALM-488 is safe and has potential to
significantly improve intraoperative, real time nerve identification. In this Direct to Phase II SBIR, Alume
Biosciences proposes to evaluate ALM-488 for efficacy to improve nerve and ureter visualization in abdominal
laparoscopic surgeries including tumor resection using FDA cleared instrumentation. They will accomplish this
with a Phase 2 multi-center trial at the University of California San Diego Health and at Stanford University
Medical Center to 1) define the ALM-488 dose in patients undergoing laparoscopic surgeries involving dissection
of the 1) diaphragmatic hiatus (Nissen, Toupet, Heller, hiatal hernia repair) and 2) pelvic dissection for colorectal
surgery (abdominal perineal resection, rectopexy, proctectomy); and 2) evaluate ALM-488 for efficacy to improve
intraoperative nerve and ureter conspicuity. Alume anticipates that clinical translation of ALM-488 will be
transformative for minimally invasive surgeries to prevent inadvertent injury and improve post-operative patient
outcomes.

Public health relevance
NARRATIVE There is an unmet need to improve the intraoperative visualization of nerves and ureters to preserve function and minimize patient morbidity following minimally invasive surgeries. Alume Biosciences has developed a novel peptide dye conjugate (ALM-488) that can be delivered intravenously before surgery as an agent to aid visualization of nerves during surgery. In this proposal, Alume proposes to complete a Phase 2 trial in patients undergoing minimally invasive abdominal surgery or tumor resection to establish efficacy of ALM-488 to improve intraoperative nerve and ureter visualization.